Neurodevelopmental Patterns of Social Reactivity in Youth at Increased Familial Risk for Bipolar I Disorder

PROJECT SUMMARY
Altered ventrolateral prefrontal cortex (VLPFC) function and brain connectivity are implicated in emotional
dysregulation and the emergence of bipolar disorder. However, our understanding of the development of
VLPFC brain networks prior to bipolar disorder onset is limited. In contrast, we have more comprehensive
knowledge of healthy adolescent brain development, specifically the profound influence of peers on
emotionally responsive brain regions and long-term mental health. This F32 research project aims to gather
feasibility and pilot data to support our central hypothesis that during late development (age 14-21), youth with
a family history of bipolar I disorder (high-risk) will exhibit altered maturation of VLPFC function and
connectivity during negative social interactions compared to youth without a family history (low-risk), which will
be closely associated with measures of emotional reactivity and dysregulation. My long-term career objective is
to become an expert in utilizing neuroimaging techniques to assess bipolar disorder risk and develop stress
resilience interventions. During this research project, I aim to enhance my neuroimaging expertise, academic
presence and knowledge in the neurodevelopment of bipolar disorder through this F32 training and hands-on
research. To test our central hypothesis, we will pursue two specific aims. Firstly, we will investigate the
neurodevelopmental maturation patterns in VLPFC activation and connectivity during peer ostracism in high-
risk compared to low-risk youth. Specifically, we will compare group differences in the relationship between
development and VLPFC response and connectivity with emotionally responsive (e.g., subgenual anterior
cingulate) and cognitively oriented brain regions (e.g., dorsolateral prefrontal cortex) during peer ostracism.
Secondly, we will investigate the relationship between VLPFC function and connectivity during peer ostracism
and emotional reactivity/regulation in both high and low-risk groups. We posit that, for both groups, VLPFC
activity and connectivity with medial prefrontal cortex, insula, striatum, and thalamus will be associated with
cyberball task distress and the ability to regulate negative emotions more generally. Additionally, we predict
that a VLPFC connectivity and other lateral prefrontal brain regions will be associated with greater emotional
resilience only in high-risk individuals, namely, less emotional reactivity and dysregulation. This study will
investigate emotional control brain networks within a developmental framework, utilizing a participant cohort of
180 youth. By studying these networks before the onset of secondary disease effects and employing age
relevant social tasks, we aim to obtain valuable pilot data for publication while refining our hypotheses for
future research and grant submissions. Findings from this study will advance our understanding of the
neuropathophysiological mechanisms preceding bipolar disorder onset, a step toward earlier intervention
during this dynamic period of emotional and social development.

Public health relevance
PROJECT NARRATIVE Ventral prefrontal-limbic networks, which are implicated in bipolar disorder and important for emotional regulation, undergo significant maturation during adolescence and young adulthood, but little is understood about the neurodevelopmental patterns within these networks which may predispose some youth to onset of the condition. By investigating the maturation of ventral prefrontal-limbic networks during negative psychosocial stress in youth with and without an increased familial risk of bipolar disorder I, we hope to better understand neurodevelopmental pathways associated with early emotional dysregulation and vulnerability to the condition. Understanding the neuropathological changes that occur during this pivotal period of social-emotional development is an essential first step towards implementing earlier interventions to mitigate long-term illness and disability well before the onset of bipolar disorder and more serious secondary progressive outcomes.